Administrative Core

Administrative Core:
Publicly-funded cancer clinical trials continue to establish new standards of care and improve
outcomes for cancer patients. ECOG-ACRIN (EA) has instituted an organizational matrix based
on the integration of biological and imaging studies with clinical trials of novel anti-cancer
therapies to conduct cutting-edge clinical research and promote scientific discovery. We have
incorporated expertise in imaging, cancer biology and therapy within our scientific organization,
working closely with the biostatistics and data management centers at the Dana Farber Cancer
Institute and Brown University, to propose a research plan that recognizes the importance of
biomarkers to bring precisely targeted clinical trials to broad populations of cancer patients. The
EA biorepositories, image databases, immunological laboratories, and associated translational
science centers will bring together the correlative science studies that relate cancer biology to
clinical markers of treatment effect in a data-rich environment. EA embraces the goals and spirit
of the NCTN to conduct science-driven clinical trials to improve the lives of adults with cancer.
EA clinical trials are implemented through an efficient operational infrastructure that enables
access to cutting-edge treatments across the US from large cancer centers to community
practices and assures accrual to complex trials in cancers of varying prevalence. Our science
is driven by our membership, which includes the NCI-funded Cancer Centers, the Specialized
Programs of Research Excellence (SPOREs), the ETCTN (Experimental Therapeutics Clinical
Trials Network), the Quantitative Imaging Network (QIN), the NCTN Lead Academic Participating
Sites (LAPS), and the National Community Oncology Research Programs (NCORP). As
committed participants in the NCTN and in all aspects of CTEP-led cancer research, EA
collaborates across the system to promote and advance the collective efforts of all of the groups.
We make available the mentorship and opportunity needed to nourish the next generation of
investigators. EA is positioned to make unique contributions to the NCTN, working to translate
NCI-supported science into improved outcomes for cancer patients. This model, together with
developing innovation in large data analysis, will yield high quality trials that have the potential to
be practice-changing, applicable to both academic and community environments, and providing
imaging and other biomarkers to identify patients who benefit most. In the Administrative Core
we outline the leadership, the structures, the functional organization and the interactions that
enable the scientific projects outlined in the Overall Operations section, and that support the
critical roles of the Clinical Trials Development Core, and their extension out to the Membership
Core. We described Idea Generation and refinement into protocol concepts in the Overall
Section, and here we describe the essential structures of the Group, together with the function of
the various core resources needed to implement the overall scientific aims of the organization,
and of the NCTN more broadly.